Image-Guided Surgical Robotic System for Femur Fracture Reduction

1 Long-bone fractures such as those in the femur afflict more than 430,000 Americans per year and are
2 rising due to the aging population. Such fractures are serious injuries that require surgery. Aligning the long bone
3 fragments requires high precision in the presence of a huge traction force and is performed manually by
4 orthopedic surgeons before fixation. Surgeons have limited visual feedback even with repeated X-ray images,
5 and rotational malalignment of 10° or more after fracture fixation occurs in 28% of patients. Complications include
6 malalignment or nonunion of bone fragments, leg shortening, soft tissue damage, and high exposure to X-ray
7 radiation.
8 This work proposes a surgical robotic system that facilitates long-bone alignment currently performed
9 manually. The long-term objectives are to build and demonstrate a surgical robot that provides a large workspace
10 for the surgeon, can provide traction forces sufficiently large to align the bone fragments without damaging the
11 bones, and provides sub-millimeter precision for alignment. Patient outcomes will be improved by decreasing
12 procedure times and eliminating complications that require repeated operations, such as leg length
13 discrepancies and abnormal gait. The first Specific Aim focus is to develop an image-guided navigation system
14 to automatically align based on surgeon selected positioning on 3D model of the bone fragments. The second
15 Specific Aim focus is to demonstrate use of a force-feedback (haptic) controller for the surgeon to sense the
16 magnitude and direction of the muscle forces and manipulate the robot to align the femur segments. The third
17 Specific Aim is (i) to develop a clinical-grade robotic system that align bone fragments, eliminate the need for
18 manually applied force during alignment, and provide an open surgical field for the surgeon, (ii) to integrate robot
19 with the navigation system and haptic controller, and (iii) evaluate its performance via cadaver testing and user
20 feedback.
21 This design-directed translational research will result in a robotic system that transforms surgical
22 practices for femur fractures and reduces complications. The use of the robot is anticipated to improve alignment
23 by 90% compared to unassisted surgery. The research lays the groundwork for future work to automate bone
24 segment alignment with a new innovative image-guided path-planning algorithm.

Public health relevance
Project Narrative Surgery to treat femur fractures is difficult as surgeons must manually apply large forces to align the broken bone fragments with limited visual feedback. Complications are frequent, including high rates of malalignment, reoperations, and mortality in the elderly. This research will develop an image-guided surgical robotic system for femur fracture surgeries that will assist the surgeon by providing sufficiently large traction forces and precise intuitive control to automatically align the bone fragments with real-time tracking of the bone.